Neonatal autonomic nervous system dysfunction as a predictor of autism spectrum disorder in preterm infants

Project Summary/Abstract
Autonomic nervous system (ANS) development begins in the prenatal period and is critical for a successful
transition to extrauterine life. ANS supports vital functions, like cardiac activity and thermal regulation, as well
as higher-level cortical processes from birth through adulthood. Adverse neonatal conditions can impair or alter
ANS function and ANS dysfunction has been associated with several neurodevelopmental impairments (NDIs),
including autism spectrum disorder (ASD). The rate of ASD in infants born preterm is more than triple that of
the general population, with reports of a 10-fold increase for very preterm (VPT) infants. Yet, the etiological link
between preterm birth and the development of ASD remains unknown. The goals of this prospective,
longitudinal study are 1) to evaluate preterm ANS dysfunction as an ASD-specific etiological mechanism in
VPT infants, using complementary measures of heart rate and thermal gradients 2) to examine whether and
how neonatal morbidities (severe brain injury, infection, bronchopulmonary dysplasia, retinopathy of
prematurity) moderate the association between ANS dysfunction and ASD/NDI outcomes and 3) to
comprehensively document emerging ASD and NDI features across the first three years of life for VPT infants,
who are at increased likelihood for both ASD and NDI. This study will quantify ANS dysfunction for VPT infants
across the NICU hospitalization to compare with the emergence of ASD-specific and NDI features across the
first three years (months 12, 24, 36). Identification of infants who are at heightened developmental risk prior to
NICU discharge is essential to guide very early intervention efforts and improve childhood outcomes.

Public health relevance
Project Narrative The current study will determine the role of autonomic nervous system dysfunction during NICU hospitalization of very preterm infants in the later emergence of autism spectrum disorder (ASD) and neurodevelopmental impairment (NDI). This work will inform models for earlier identification of ASD and NDI within the first year of life in very preterm infants to identify children most in need of very early intervention, for improvement in long- term outcomes.